Topical Eyedrops Increasing Lysyl Oxidase and Dopamine Activity to Control Myopia

Project Summary
Pediatric myopia is affecting approximately one-third of children and adolescents 1, and is increasing globally at
an alarming rate with significant increases in pathologic conditions associated with high myopia including retinal
detachment, maculopathy, cataract and glaucoma. It is the leading cause of vision impairment in the world. A
recent report from the National Academies of Science, Engineering, and Medicine recommends classifying
myopia as an official disease that requires a medical diagnosis 2.
Currently, there are no FDA-approved pharmacologic therapies to slow the progression of myopia. We propose
a novel topical eyedrop, IVMED-85 for treating myopia. It is a first-in-class medication delivering copper to
upregulate lysyl oxidase (a cuproenzyme the activity of which is deficient in myopic sclera) to pharmacologically
induce scleral and corneal crosslinking, and biomechanical strengthening of both tissues.
In our phase 1 project, we demonstrated the efficacy of our eyedrops in juvenile myopic guinea pigs, by slowing
axial lengthening and reducing myopia progression compared to control. We also demonstrated stability of
formulation for 12 months in long-term and 6 months accelerated conditions according to ICH guidelines. With
internal funding, we have completed two GLP toxicology studies in juvenile species according to our pre-IND
meeting with the FDA.
In this phase 2 project, we propose 3 specific aims that will enable us to submit an IND with a well thought clinical
protocol to start US clinical trials. First, we will confirm biochemical effects of our eyedrop on a key biomarker of
crosslinking, and determine if the effect of therapy is durable after cessation of treatment, or if there is a rebound
myopic progression. Second, we will confirm if our copper eyedrops increase retinal dopamine synthesis through
up-regulation of the importance of copper in dopamine synthesis in retina cells, which could improve choroidal
thickness and reduce scleral hypoxia. This mechanistic data will add further patent protection to IVMED-85 and
will enhance competitive additional advantage over other potential treatments. Third, we will complete GMP
manufacturing for clinical trials and assess long-term stability of the eyedrop.

Public health relevance
Project Narrative Pediatric myopia (near-sightedness) is a leading cause of poor vision in the US and around the world. Early onset of pediatric myopia is linked to serious eye conditions including retinal detachment, myopic maculopathy, cataracts, and glaucoma. Poor vision affects schooling, career prospects, and lifetime productivity. We propose a novel eye drop to treat pediatric myopia, which enhances natural corneal and scleral crosslinking as well as dopamine levels in retina, without any of the side effects seen with current off-label treatments.